Protection of at-risk low birth weight infants against influenza via maternal antibody

PROJECT SUMMARY / ABSTRACT
Acute respiratory infections are the leading cause of mortality among neonates globally, particularly among low
birthweight infants from pregnancies complicated by prematurity or placental insufficiency. Maternal immuniza-
tion, the vaccination of pregnant women to enhance antibody transported across the placenta to the fetus, is
utilized increasingly as an infection prevention strategy to protect neonates from pathogens such as influenza,
and may be critical as new vaccines against SARS-CoV-2 are developed. This proposal aims to better eluci-
date transplacental antibody transfer in low- and high-risk pregnancies, specifically those with prematurity or
placental insufficiency, which is not known. It also describes a research training program that will allow me to
become an independent physician-scientist with a translational research program focusing on infectious
diseases and vaccines in pregnancy. This proposal builds upon my training in high-risk obstetrics and global
health, and provides a detailed plan to improve my knowledge of virology, immunology, vaccinology, cohort
studies and statistical analysis. It incorporates the expertise of an outstanding mentorship team, including
experts in infectious diseases, immunology, pathology, statistics, and computational biology who are dedicated
to the success of this project and the development of my career as an independent clinical researcher.
The first aim of this proposal involves establishing normal and high-risk pregnancy cohorts and quantifying
transplacental antibody transfer in the context of pregnancies resulting in both normal and low birth weight
infants, including those complicated by placental insufficiency leading to small for gestational age infants or
prematurity. I will compare quantity of transplacental antibody transfer of total IgG, influenza- and SARS-CoV-
2- specific antibodies, and expression of neonatal Fc receptor in placentas. I will also compare neonatal
immunity against influenza among women who did and did not receive influenza vaccine during pregnancy,
allowing the opportunity to develop multivariable models and adjust for multiple clinical covariates. For my
second aim, I will characterize antibody profiles and transplacental transfer in the same cohorts using a
systems serology approach to determine biophysical and effector functions of maternal and fetal immunology.
Through accomplishing the aims in this proposal, I will contribute significantly to our knowledge of maternal
immunizations, maternal and neonatal immune interactions and neonatal immunity against influenza and
SARS-CoV-2. Improved understanding and characterization of transplacental antibody transfer in the context
of maternal immunizations may provide insight in the optimization and individualization of vaccine delivery and
timing in high-risk pregnancies and, ultimately, has the potential to improve neonatal survival globally. This
proposal will allow me to develop a unique set of cross-disciplinary skills and expertise in order to transition to
independence as a physician scientist with a larger research program specializing in respiratory infectious
diseases and vaccines within the context of low- and high-risk pregnancies.

Public health relevance
PROJECT NARRATIVE Acute respiratory infections are among the leading causes of neonatal mortality worldwide with low birth weight infants particularly susceptible and at risk for perinatal mortality. Maternal immunizations are increasingly being used as an infection prevention strategy to protect neonates and infants from respiratory pathogens, yet maternal immunization and transplacental antibody transfer are incompletely understood in pregnancies complicated by prematurity or placental insufficiency leading to small for gestational age infants. This proposal aims to quantify and characterize transplacental antibody transfer and maternal and neonatal immune interactions in these high-risk pregnancies in order to optimize neonatal immunity against respiratory pathogens such as influenza and SARS-CoV-2 in at-risk low birth weight infants.